Evaluation of genetic and metabolic markers in the development of urinary urgency incontinence

Project Summary:
Urinary urgency incontinence (UUI) is one of the most common conditions to impact women,
and older women, in particular. When comparing women with and without urgency incontinence,
those with UUI have lower quality of life scores and higher rates of anxiety and depression.
While the incidence and prevalence of UUI has been well studied, the pathophysiology of the
disease is poorly understood. In the majority of cases, UUI is classified as idiopathic or “age-
related”. In these cases, there are likely numerous genetic, environmental, dietary, metabolic
and clinical factors and inter-factor interactions that lead to the development of UUI and these
interactions likely center around the disturbance of normal neural signaling which controls
micturition. Improving our understanding of how UUI develops in women without an overt clinical
condition and how the cholinergic signaling system is involved will likely contribute to an
individualized treatment paradigm for managing UUI as well as the development of novel
treatments. In this proposal we will use the robust longitudinal data present in the Nurses’
Health Study (NHS) and NHS II to classify the plasma levels of cholinergic metabolites in
women with and without. We will investigate whether non-cholinergic metabolites and single
nucleotide polymorphisms for UUI lead to this condition and how interactions between these
variables and cholinergic metabolites and clinical and demographic risk factors lead to the
development of UUI. We will also evaluate how dietary choline impacts the presence of
cholinergic metabolites, and whether this interaction is associated with expression of the UUI
phenotype.

Public health relevance
Project Narrative: Urinary urgency incontinence is a major public health concern affecting over 40 million people, primarily women, in the United States alone. Our understanding of how and why urgency incontinence develops is incomplete which prevents efficient diagnosis and treatment. The results of this study will not only fill a significant knowledge gap in understanding the etiology of UUI, but will provide a potential method of differentiating phenotypes of UUI and potential targets for intervention.